Feed-forward regulation between GPR120 and PPAR gamma.

PROJECT SUMMARY/ABSTRACT
Pathologic expansion of white adipose tissue (WAT) in obesity is characterized by adipocyte hypertrophy,
inflammation, and fibrosis; however, factors triggering this maladaptive remodeling are largely unknown.
Moreover, adipose precursor cells (APCs) exhibit reginal variation in response to obesity, for unclear reason. In
the next funding cycle, we will focus on the healthy adipogenesis and test the hypothesis that the potential to
recruit new adipocytes from PDGFRβ+ APCs determine WAT health in obesity. We manipulate levels of PPARγ,
the master regulator of adipogenesis with or without GPR120 stimulation, in APCs of adult mice to determine
whether increasing the adipogenic capacity of APCs through GPR120 stimulation-mediated PPARγ
overexpression results in healthy WAT expansion in obesity. In addition to examine the negative effect of loss of
mural cell GPR120 in WAT expansion upon high-fat diet feeding, we also hypothesize the precise molecular
mechanism that how GPR120 activation drives modulation of PPARγ activity in APCs and inhibition of
inflammation in fibro-inflammatory progenitor cells (FIPs) under obese condition. The concept, which we
suggested in the previous funding cycle, that the combination of PPARγ and GPR120 activation has been shown
as additive effects as well as using much lower doses of PPARγ agonist, TZDs to mitigate unwanted side effects
in combination with GPR120 agonist, compound A (CpdA). Thus, in this renewal application, we determine the
effect of the PPARγ and GPR120 activation in healthy WAT remodeling is dependent on mural cell PPARγ and
GPR120 feed-forward regulation with GPR120 stimulation-mediated anti-inflammatory effects. Our studies
highlight the potential for APCs to be targeted pharmacologically to improve metabolic health in obesity.

Public health relevance
PROJECT NARRATIVE This project builds on our new discovery that the GPR120 stimulation in adipose progenitor cells leads to healthy white adipose tissue remodeling via positive reinforcing effects with PPARγ under high fat diet-induced obese condition. The current renewal proposal is designed to study the cellular and molecular mechanisms of GPR120 stimulation-mediated effects in adipocyte precursor cells (APCs) and fibro-inflammatory progenitor cells (FIPs) of white adipose tissue which will mitigate obesity-induced adipose tissue dysfunction. This study should lead to a better understanding of how GPR120 plays a role to regulate adipogenesis and healthy adipose tissue remodeling to ultimately improve metabolic health in obesity.